The double-stranded RNA (dsRNA) response in gastric pre-neoplasia

PROJECT SUMMARY / ABSTRACT
Gastric cancer is a leading cause of cancer-related deaths worldwide and carries a dismal prognosis in
the United States. A critical pre-neoplastic stage and determinant of oncogenic risk is the development of pyloric
metaplasia. However, we still have a limited understanding of how pyloric metaplasia develops and expands in
the setting of chronic inflammation. My laboratory’s long-term goal is to characterize new and potentially
targetable pathways in pyloric metaplasia.
We recently and unexpectedly identified the response to double-stranded RNA (dsRNA) as the most
upregulated pathway across two distinct models of murine pyloric metaplasia. dsRNA signaling was initially
described as an innate immune response that induces type I interferons (IFNαβ) during viral infection. Its role in
gastric pre-neoplasia had not been studied, however. Our previous work confirmed that dsRNA accumulates in
metaplastic gastric epithelium in germ-free mice and in humans, and recent evidence indirectly suggests that
the response to dsRNA is downregulated in human gastric cancer. dsRNA signaling therefore represents an
under-appreciated pathway in gastric epithelial injury and tumorigenesis.
The objective of this proposal is to establish how dsRNA signaling contributes to gastric pre-neoplasia.
To address this, we specifically deleted a central regulator of dsRNA signaling, ADAR1, from gastric parietal cells
(Adar1ΔPC). Consistent with a role for dsRNA signaling in pre-neoplasia, Adar1ΔPC mice spontaneously developed
pyloric metaplasia and gastric dysplasia. Further molecular characterization found that mitochondrial RNA (mt-
RNA) accumulated within the gastric epithelium of Adar1ΔPC stomachs, implicating mt-RNA as a potential trigger
of epithelial dsRNA signaling. Single-cell RNA sequencing and flow cytometric analyses demonstrated a
sustained and transcriptionally upregulated dsRNA response throughout the gland that was independent of
adaptive immunity. We have therefore developed a tractable model of gastric pre-neoplasia that we will use to
understand how dsRNA signaling promotes a pre-cancerous gastric environment. Aim 1 will examine how distinct
sources of dsRNA activate dsRNA signaling within gastric epithelium, using an established gastroid system, new
murine models, and innovative in vitro approaches. Aim 2 will rely on genetic mouse models and bone marrow
chimera experiments to determine how epithelium- and immune-mediated IFNαβ signaling connects the dsRNA
response to gastric pre-neoplasia.
The proposed experiments are logical extensions of our previous work. They also establish new
foundational tools and exciting research avenues that can be completed within the award period. The importance
of this application is to enhance our mechanistic understanding of a previously unexplored and therapeutically
targetable pathway in gastric pre-neoplasia that can be broadly applied to pre-neoplastic states across other
epithelial tissues.

Public health relevance
PROJECT NARRATIVE Pyloric metaplasia represents a critical transition in the progression to gastric cancer, a leading global cause of cancer-related deaths. We previously showed that the double-stranded RNA (dsRNA) response, an innate immune pathway that has been typically considered anti-viral, was highly upregulated during pyloric metaplasia in mice and humans, and we have developed a new genetic mouse model of pyloric metaplasia/gastric dysplasia by dysregulating the dsRNA response within gastric epithelium. Leveraging this model, the main objective of this proposal is to establish the molecular and cellular mechanisms by which the dsRNA response promotes gastric pre-cancerous changes, thereby providing novel insight into an under- appreciated pathway that can be therapeutically targeted.